Arousal and Timekeeping in a Mouse Model of Parkisonism (Supplement)

PROJECT SUMMARY / ABSTRACT
This is an application for an administrative supplement to the original R15 application "Arousal
and Timekeeping in a Mouse Mode of Parkinsonism" to extend our studies to mouse models of
Alzheimer's Disease. Neurodegenerative disorders like Parkinson’s Disease (PD), Huntington’s
Disease, and Alzheimer's Disease (AD) are characterized by drastic impairments in planning, as
well as cognitive deficits, some of which stem from deficits in estimating durations. Estimation and
reproduction of durations in the seconds-to-minutes range are critical for fundamental processes
such as associative learning, planned motor responses and decision-making. We propose to
extend the original project to evaluate timed motor response deficits in a mouse model of AD. We
will investigate the role of arousal in alterations of timed response selection using a newly
developed model of timed response selection deficits. We will also evaluate pharmacological
approaches to rescue motor timing deficits. The project will enhance our understanding of
neuronal processes involved in cognitive and motor control deficits in neurodegenerative
disorders, and will help develop new treatment strategies in animal models, with possible
subsequent impact on clinical treatments.

Public health relevance
PROJECT NARRATIVE Neurodegenerative disorders such as Parkinson’s Disease, Huntington’s Disease, and Alzheimer’s Disease are characterized by drastic impairments in planning and decision making, some of which stem from deficits in estimating durations. By investigating timekeeping we aim to understand the circuits involved in planning and decision making. The project will enhance our understanding of the role of these circuits in cognitive control, and will help assessing potential treatment strategies in animal models with subsequent impact on clinical treatments.